Administrative Core

ABSTRACT
The overall objective of the Roswell Park Ovarian Cancer SPORE Administration Core is to provide leadership,
direction, scientific and fiscal oversight, and administrative services for the purposes of enhancing research
productivity and maintaining a stimulating research environment conducive to translational research in ovarian
cancer. Importantly, the Administration Core will catalyze, oversee, and support interactions amongst SPORE
components, external and internal collaborators, other SPOREs, patient advocates, and the National Cancer
Institute (NCI). In order to achieve the overall objective of managing SPORE resources and maintaining high
quality in all components, the Administration Core will be organized into four main operational areas, the
provision of 1) Leadership; 2) Administrative Management; 3) Clinical Trials, Data, and Communications
Management; and 4) Scientific Management. This management and support is accomplished through an
organizational framework that takes advantage of highly experienced leadership that is integrated within
Roswell Park Comprehensive Cancer Center, an oversight executive committee for planning and evaluation of
activities, and scientific and patient advocate advisors. The functions performed by the Administration Core will
provide greater integration and efficiency across the program and will result in lower operating costs for each
individual Roswell Park Ovarian Cancer SPORE component.

Public health relevance
NARRATIVE The Administration Core will serve the Roswell Park Ovarian Cancer SPORE's overall translational research objectives by providing effective leadership and administrative support for a broad range of SPORE-related activities to ensure optimal progress and performance of all leaders, investigators, projects, cores, and developmental programs. The Core's responsibilities include direct support to investigators, planning, coordination and management of all scientific and administrative collaborations with the NCI, other SPOREs, partner institutions, and facilitating interactions and collaborations with the patient and advocate community.